Influence of the nasal microbiome on host susceptibility and response to respiratory viruses

PROJECT SUMMARY
The nasal cavity has a unique microbiome, which is expected to significantly affect local immune response
and in turn, susceptibility of the host to respiratory viruses. However, we know little about these potential host-
microbe interactions. Our long-term goal is to elucidate how microbiome-immune interactions and dynamics
within the nasal cavity affect host susceptibility to infectious and inflammatory conditions. This project’s
objective is to determine natural dynamics of correlations between nasal microbiome and local immune
environment and how this relationship affects host susceptibility to respiratory viral infections. Our central
hypothesis is that during homeostasis, the nasal microbiome impacts local antiviral immune defenses,
including epithelial integrity, mucus properties, and antiviral cytokines and specific nasal microbiome-immune
environments defined by low-inflammation and high-interferon levels will confer greater natural protection
against respiratory viral infections. The rationale for this project is that our knowledge regarding the adult
nasal microbiome and immune environment during homeostasis is limited. Addressing this gap can
immediately improve our fundamental understanding of the adult nasal cavity and inform strategies that
promote naturally occurring protection against respiratory viral infections.
Aim 1. Elucidate dynamics of the homeostatic nasal microbiome and immune environment in adults.
We will achieve this aim by studying (i) the homeostatic nasal microbiome and innate immune profile in a
cross-section of adults (n = 400) and (ii) assessing short- and long-term dynamics of adult nasal environment
by selecting and following 118 adults through monthly and quarterly dense sampling over a 12-month period.
Aim 2. Determine how the nasal microbiome-immune environment affects susceptibility to an intra-
nasal virus challenge. We will achieve this aim by studying how pre-vaccination nasal microbiome-immune
environments impact post-vaccination viral infection and replication among adult FluMist® recipients (n = 200)
per year in Years 1 and 2.
Aim 3. Elucidate interactions between nasal microbiome, nasal immune environment, and host
susceptibility to respiratory viruses in vitro. We will achieve this aim by assessing effect of nasal
microbiome composition and nasal bacterial absolute abundance on: (i) innate immune defenses and (ii)
influenza A, rhinovirus, and SARS-CoV-2 infectivity using an innovative in vitro nasal microbiome-respiratory
epithelial co-culture model.
The proposed research is innovative because it represents a departure from the status quo by assessing
how the nasal microbiome, which is ubiquitous and diverse, could affect natural immune environment.
significant because it is expected to identify nasal microbiome features and immune profiles that confer
natural antiviral protection, which could inform novel strategies to reduce the risk for respiratory viral infections.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health, because little is known about how nasal microbiome could affect natural-occurring immune protections in the nasal cavity of adults, which can affect the adult population’s risks for respiratory viruses such as coronaviruses, influenza, and rhinovirus. By studying nasal microbiome and these important types of immune response, this project will build new knowledge on the natural immune protection in adults against respiratory viral infections. Therefore, the proposed research is relevant to the NIH mission to better understand and prevent infectious diseases, including those caused by influenza, coronaviruses (including SARS-CoV-2), and other respiratory viruses.